Direct chemical control of the hematopoietic master transcription factor PU.1

PROJECT SUMMARY/ABSTRACT: Direct control of the hematopoietic master transcription factor PU.1
Hematopoiesis, the process by which all lineages of blood cells are derived, is under coordinate control by a
restricted group of transcription factors. Currently, factor-specific control relies heavily on genetic methods, such
as RNA interference and CRISPR/Cas9, to alter the expression of transcription factors of interest. While highly
selective, gene-based approaches are associated with significant latency (many hours to days) and therefore
cannot access critical cellular dynamics at timescales in the minute-to-hour régime. Moreover, cytotoxicity and
genotoxicity due to viral and non-viral gene delivery remain outstanding issues, particularly in therapy. Direct
chemical control of specific transcription factors could address these opportunities, but a general lack of
endogenous ligands for medicinal chemistry and broad structural homology challenge drug discovery. To meet
this challenge, we have translated the disposition of molecular hydration in factor/DNA recognition into an
orthogonal selection criterion to library screening. As proof of concept, we developed an osmotically driven phage
display screen to obtain short peptides that enhance or inhibit DNA binding by PU.1, a master transcription factor
in hematopoietic stem cell homeostasis and differentiation. De-regulation of PU.1 represents a major molecular
lesion in several hematopoietic malignancies (e.g., acute myeloid leukemia, multiple myeloma, and Hodgkin's
disease) as well as fibrosis of the lungs, liver, and kidneys. The objectives of this proposal are: to validate the
biological and molecular properties of PU.1-targeted peptides, and adapting the osmotic screening technique to
target other transcription factors that function in concert with PU.1. To achieve these objectives, we propose
three specific aims. 1) We will define the functional profiles of PU.1-targeted peptides in cultured hematopoietic
models, as well as primary murine and patient-derived leukemic and pro-fibrotic cells. Preliminary data show that
PU.1-targeted peptides enter the cell nucleus and modulate the expression of major PU.1 target genes in as
little as 30 min, an onset well below currently achievable limits by genetic manipulations. Our proposed studies
are aimed at characterizing their transcriptional profiles and the attendant changes in cellular and disease
phenotypes. 2) We will determine the molecular properties of peptide modulation of factor/DNA recognition.
Detailed studies are aimed at dissecting the diverse structural and mechanistic bases of peptide/complex
interactions. 3) We will expand osmotic screening to target lineage-specific transcription factors that co-regulate
with PU.1, including the interferon regulatory factors IRF4 and IRF8 that bind DNA cooperatively with PU.1, as
well as partners such as C/EBPα that are recruited collaboratively by low-affinity PU.1 binding. In summary, this
proposal is expected to advance transcription factor pharmacology with novel targeted reagents, particularly
activators, and demonstrate the combination of structural and physicochemical interrogation (library panning +
osmotic pressure) as a tractable, generalizable solution to overcome current bottlenecks in chemical control.

Public health relevance
PROJECT NARRATIVE: Direct chemical control of the master hematopoietic transcription factor PU.1 This proposal is aimed at developing new agents to control molecular regulators involved in the development of blood cells. These compounds will enable new investigations into the molecular events of blood development, with potential to give rise to novel therapies for several blood-borne cancers and diseases of the lungs, liver, and kidneys.